Animal Medicine Infrastructure Support - Animal Care

..............................................................................................................................................................................................................................................................................................................................................................................................................................................................................................................................................................................................................................